Vanderbilt-Nigeria Research Administration and Management Training Program (V-RAMP)

PROJECT ABSTRACT
The increasing volume and complexity of research activities at the Aminu Kano Teaching Hospital (AKTH) in
Kano, Nigeria necessitates urgent measures to improve research infrastructure in grants administration and
management. The overall goal of this training program is to build infrastructure capacity in research
administration and management and research ethics at AKTH in Nigeria to support the many HIV-related
research projects and clinical trials, both planned and underway, at this site. To achieve the aims outlined in this
application, we will perform a mixed methods needs assessment of the research administration and management
environment in AKTH in year 1 and generate an Action Plan that will identify infrastructure needs, prioritize
processes, and guide program implementation. We will capacitate the newly established AKTH Office of
Research Administration and improve the knowledge and skills of AKTH research administrators and grant
managers via short term in-person trainings at Vanderbilt, in Kano, Nigeria and by remote learning opportunities.
We will enhance the administrative efficiency and performance of research ethics operations at AKTH through
training and mentoring of AKTH IRB members and office staff and the development and implementation of
systematic processes to streamline protocols, to include a REDCap protocol tracking database and standard
operating procedures in research ethics and responsible conduct of research. The proposed infrastructure
training award will enable the creation of a high-quality research administration environment at AKTH that is
knowledgeable and compliant with the fiscal, management, and ethical standards of sponsored HIV-related
research.

Public health relevance
PROJECT NARRATIVE Expansion of research activities at the Aminu Kano Teaching Hospital (AKTH) in Kano, Nigeria presents a unique opportunity to strengthen research administration and management capacity in HIV research. This program harnesses the longstanding and highly successful research partnership between AKTH and the Vanderbilt Institute for Global Health to establish a research administration management platform that will create a cohort of highly skilled Nigerian research administrators that is knowledgeable and compliant with the fiscal, management, and ethical standards of sponsored HIV research.